Role of DJ1 in mitochondrial biogenergetics and neuronal metabolism

Abstract
Jonas, EA
Familial Parkinson’s disease (PD) protein DJ-1 mutations are linked to mitochondrial deficits and
early onset PD but the exact mechanisms are unclear. We have found that mutations in DJ-1 and
DJ-1 knock out increase mitochondrial uncoupling and hamper extension and branching of
dopaminergic neuronal processes. The uncoupling is associated with abnormal ATP synthase
efficiency and stoichiometry. The changes in ATP synthase are also associated with mitochondrial
morphological changes including changes in cristae number, mitochondrial length and
mitochondrial biogenesis. New protein synthesis is crucial to repair and maintain dopaminergic
endings in the striatum and for normal dopamine release capacity. The activation of new protein
synthesis is in response to cues such as growth factors or neuronal stimulation, but we
hypothesize that new protein synthesis fails to occur when the stoichiometry of the ATP synthase
is abnormal. In keeping with this, we find that protein synthesis levels are very low in patient cells
and in DJ-1 KO mouse neurons. DJ-1 is bound to ATP synthase β subunit and ATP synthase β
subunit mRNA. We therefore hypothesize that the mechanism of decreased growth and branching
of DJ-1 deficient dopaminergic neurons is related to a lack of DJ-1 targeted, mitochondrially-
regulated, mRNAs that are required for neuronal growth, repair and plasticity of dopaminergic
cells. If we can restore the normal rate of protein synthesis downstream of DJ-1 in a spatially and
temporally precise manner, we hypothesize we will slow neuronal ending degradation in DJ-1
mutant patients and preserve dopamine release capability. In keeping with this, we have now
restored protein synthesis rates in patient cells by overexpression of ATP synthase β subunit. We
now plan to determine if we can rescue low protein synthesis rates and neuronal growth in DJ-1
KO neurons, in neurons expressing mutant DJ-1 and in vivo in DJ-1 KO animals. We will do this
by overexpression of ATP synthase β subunit by AAV (viral) delivery in neurons. In vivo, we will
restore the normal coupling of mitochondria by crossing the DJ-1 KO mice with a low c-subunit
leak KI mouse. We will restore the normal ATP synthase stoichiometry in vivo by crossing the DJ-
1 KO mouse with a mouse overexpressing ATP synthase β subunit. We hope to preserve
neuronal endings in the striatum and prevent the onset of dysfunctional movement in the mice.
Our observations suggest a connection between ATP synthase complex stoichiometry, protein
synthesis rates and PD. Our plan comprises a promising new strategy to develop therapies for
PD patients.

Public health relevance
Familial Parkinson’s disease (PD) protein DJ-1 mutations are linked to mitochondrial deficits and early onset PD. In this study, we will determine if dopaminergic neuronal growth and repair are dependent on changes to mitochondria that improve ATP synthase efficiency and rate of protein synthesis.